Natural audiovisual speech encoding in the early stages of the human cortical hierarchy

PROJECT SUMMARY
Seeing a speaker’s face can greatly improve one’s ability to understand what they are saying, especially under
adverse hearing conditions. This phenomenon has been attributed to the multisensory integration of audio and
visual speech. Decades of research suggests that such integrative mechanisms come in two forms based on
“when” the audio and visual speech are integrated: 1) early integration at the acoustic level, before speech
acoustics have been transformed into linguistic representations; and 2) late integration at the linguistic level,
where the visual system supplies its own linguistic representations that constrain the inferences being made
about audio speech. This has led some to propose that audiovisual speech integration is a multistage process.
However, the multistage models that have been proposed lack detail on how speech acoustics and visible
articulations are initially transformed into linguistic representations. And, more generally, they have been vague
on how visual speech constrains linguistic categorization. Progress on updating these models has been slow
over the past decade, in large part because the field has overly relied on – admittedly interesting and important
– paradigms involving discrete (often illusory) speech stimuli. To fully characterize early integrative processes –
likely based on the correlated dynamics of visual and auditory speech – and later integrative processes – likely
based on how the form of visual articulators helps with linguistic categorization – surely requires the use of
ongoing, natural audiovisual speech. In this project, we propose an updated model of multistage audiovisual
speech processing. This model is built on the hypothesis that hierarchical speech processing occurs in both the
auditory and visual systems – and that different hierarchical speech representations in the visual system flexibly
influence different hierarchical levels of processing in the auditory system, depending on the quality of the
acoustic input and the task. We aim to test several predictions generated by this model. A first prediction is that
correlated motion from visual speech enhances auditory selective attention and, thus, auditory cortical sensitivity
to acoustic speech, while visual articulatory cues enhance the categorization of auditory speech into linguistic
units. A second prediction is that visual speech aids in speech recognition according to an information theoretic
process at the sub-lexical (i.e., phoneme-by-phoneme) level. Finally, we predict that different visual speech
representations differentially influence audio speech processing as a function of acoustic experience/quality. We
will test this by characterizing such processing in people who vary in their level of acoustic speech experience,
namely deaf individuals who do and do not use cochlear implants, as well as typically hearing individuals.
Ultimately, this project will provide a rigorous test of an updated model of natural audiovisual speech processing
in the human brain. We also expect it to produce methods, paradigms and measures that will be valuable in
future basic and clinical research. And we have assembled a team that is ideally suited to deliver on these goals.

Public health relevance
PROJECT NARRATIVE Seeing a speaker’s face in a noisy environment can greatly improve one’s ability to understand what they are saying, a process that is attributed to the multisensory integration of audio and visual speech. This project aims to introduce an updated model of such multisensory integration that is built around the hypothesis that visual cortex represents both low-level visual features and higher-level linguistic cues and that these representations can differentially and flexibly influence the processing of audio speech. We will test this hypothesis by modeling neurophysiological data – collected in typically hearing individuals, as well as deaf individuals who do and do not use cochlear implants – across a series of experiments involving natural visual, audio, and audiovisual speech.